Longitudinal Associations of Posttraumatic Stress Disorder with Incident Type 2 Diabetes and Poor Glycemic Control in a Large National Cohort

Project Summary
This K08 Mentored Clinical Scientist Development Award will provide Dr. Kelsey Serier with training to develop
an independent research career devoted to understanding the effect of trauma and trauma-related negative
mental health sequalae, namely posttraumatic stress disorder (PTSD), on the development and course of type
2 diabetes (T2D). Dr. Serier has assembled an impressive interdisciplinary mentorship team comprised of
experts in trauma, behavioral science, epidemiology, endocrinology, and health informatics to support her
development and successful completion of the proposed training and research goals. Through a
comprehensive and carefully designed training plan, Dr. Serier will address previous training gaps and develop
skills in (1) domain-specific knowledge related to PTSD and T2D, (2) epidemiologic methods and longitudinal
data analysis, and (3) professional development and grant writing. A cross-cutting training goal is furthering her
skills in conducting interdisciplinary team science. The proposed research program leverages the largest
electronic health record cohort of individuals at risk of T2D (n = 6,082,018) in the United States. Data come
from the Veteran’s Health Administration and includes an extensive set of clinician-based diagnoses,
laboratory tests, and up to 15 years of follow-up data. Utilizing this cohort, the current study aims to address
several critical gaps in our current knowledge of PTSD and T2D, specifically: (1) a lack of prospective data that
include clinician-derived diagnostic information, (2) minimal consideration of psychiatric comorbidity, (3) limited
investigation of PTSD on outcomes in individuals with T2D, including glycemic control, and (4) an absence of
studies considering the impact of sex, race, and ethnicity. Aim One will estimate the effect of PTSD,
depression, and their comorbidity on the rate of T2D using cox proportional hazard models and interaction
contrasts. Aim Two will include individuals who developed T2D during the study period (n = 936,596). A series
of conditional logistic regression models and interaction contrasts will be used to estimate the odds of poor
glycemic control in PTSD, depression, and their comorbidity relative to non-psychiatric comparison groups.
Aim Three will examine the extent to which sex, race, and ethnicity modify the associations in Aims One and
Two. The current study includes a large number of women (n = 504,002) and individuals identifying as non-
Hispanic Black (n = 888,465), and Hispanic and Latino (n = 331, 817) to allow for analyses examining the
differential effect of PTSD on T2D in subpopulations with a higher burden of disease. The unique data source
and methodological rigor of the proposed study offers an efficient way to examine the associations between
PTSD and a range of T2D-related outcomes, which will ultimately inform targeted T2D prevention and
intervention approaches. Furthermore, the project will provide the applicant with essential interdisciplinary
training for an independent and integrative research program examining associations between the
psychological sequalae of trauma and T2D.

Public health relevance
Project Narrative The proposed project leverages a unique longitudinal cohort of over 6 million individuals to examine the extent to which posttraumatic stress disorder (PTSD), a psychiatric disorder that can develop after trauma exposure, is associated with incident type 2 diabetes and poor glycemic control in individuals who developed type 2 diabetes during the study period. This study also will investigate the extent to which associations between PTSD and type 2 diabetes differ across sex, race, and ethnicity. This work has the potential to advance our knowledge about factors that contribute to type 2 diabetes risk and ultimately may have implications for tailoring diabetes-related prevention and intervention efforts for individuals with PTSD.